Cardiovascular reserve capacity in survivors of hematopoietic cell transplantation

Abstract
There are currently 200,000 hematopoietic cell transplantation (HCT) survivors in the U.S today, a number that
will exceed 500,000 by 2030. Despite improvements in overall survival, long-term HCT survivors remain at high
risk for chronic health complications such as cardiovascular disease (CVD). Cardiovascular complications,
such as myocardial infarction and cardiomyopathy/heart failure, are not only more common in HCT survivors,
but they occur earlier than in the general population; in essence, HCT is associated with accelerated
cardiovascular aging. However, as highlighted by the recent NIH HCT Late Effects Consensus Conference, the
biological mechanisms underlying this problem remain unknown. Our overall hypothesis is that multiple
sequential organ system and metabolic impairments sustained prior to, during, or after HCT accelerates
depletion of cardiovascular physiologic reserves (cardiovascular reserve capacity), predisposing to early onset
CVD. To test this hypothesis, we will measure cardiovascular reserve capacity in a group of HCT survivors
over time. Peak oxygen consumption (VO2peak), as derived from cardiopulmonary exercise testing, is the gold
standard measure of cardiovascular reserve capacity, because it represents the integrative efficiency with
which multiple organ systems deliver and use oxygen for ATP resynthesis. Using a longitudinal study design,
we will evaluate VO2peak at baseline (prior to HCT), 6 months, one year and two years post-HCT, allowing us to
determine its trajectory over time. We will also determine the impact VO2peak on self-reported physical
functioning, and identify populations at high risk for accelerated VO2peak decline after HCT (Aim 1). Importantly,
we will use novel diagnostic strategies to define the organic-specific determinants of VO2peak and its impairment
after HCT (Aim 2). By the end of our study, we will have: 1) established initial VO2peak in patients undergoing
HCT and characterized its post-HCT trajectory over time, identifying patients at highest risk for decline after
HCT; 2) informed the screening for subclinical CVD, using strategies that are readily applicable in the clinical
setting; and 3) identified mechanisms by which organ-specific impairments, alone and in combination,
contribute to abnormalities in VO2peak after HCT. This proposal builds on our previous successful research and
will address important knowledge gaps about cardiovascular complications in HCT survivors. Information
obtained from this proposal will support development of evidence-based interventions to decrease the risk of
CVD after HCT. The growing population of long-term HCT survivors makes development of prevention
strategies imperative, to ensure that these survivors live long and healthy lives well after completion of HCT.

Public health relevance
Project narrative Cardiovascular complications, such as heart failure and heart attack are some of the most devastating long- term problems faced by hematopoietic (stem) cell transplantation survivors, and are a common cause of premature death for this vulnerable population. To better understand these complications, we plan to measure stem cell transplantation survivors' cardiovascular health over time, using tests of their heart, lungs, muscles, and other organs. We will use this information to one day prevent cardiovascular complications in hundreds of thousands of stem cell transplant survivors.